Mechanisms of p53 Engagement and Action at the Benign-to-Malignant Transition in Sporadic Tumorigenesis

PROJECT SUMMARY
The transcription factor p53 is one of the most critical barriers to tumorigenesis. p53 is mutated in over half of
all human tumors, and p53-mutant tumors typically carry a worse prognosis. As a tumor suppressor, p53
appears to act at the transition from benign to malignant disease, preventing transformation of cells that have
already acquired some pro-tumor features, such as oncogene activation or DNA damage. Decades of research
have sought to identify what makes p53 a potent tumor suppressor, as such knowledge could inform effective
strategies for cancer prevention and treatment. This research has shown that p53 can be activated by a variety
of signals, and in turn activated p53 can regulate a wide variety of cellular processes, including cell survival,
senescence, genomic stability, and plasticity. However, the inducers and actions of p53 vary with context, and
there is still no consensus on what signals engage p53 during early neoplasia and what biological programs
are most important for its tumor-suppressive functions. Furthermore, we still do not know the key events
following p53 loss that enable transition to malignancy. Attempts to gain this knowledge have been hampered
by a lack of tools to directly study p53 in the specific cells undergoing transformation within endogenous
contexts. To address these gaps in knowledge, we will study the events surrounding p53 activation and loss
during the initiation of pancreatic ductal carcinoma (PDAC), an aggressive cancer in which p53 loss—which
occurs in 70% of PDACs—enables progression from benign precursor lesions to full-blown cancer. We
recently developed new mouse models of PDAC that allow us to “see” p53 in action as cells progress through
the benign-to-malignant transition. Among the premalignant pancreas cells, we discovered a subpopulation
that shares many transcriptional features with established tumor cells, and thus these cells appear to be
transitioning from premalignant to malignant. These transitioning cells are also the cells with the strongest p53
activation, and so they provide a unique opportunity to study p53 engagement and tumor-suppressive function
at the benign-to-malignant transition. Using single-cell transcriptional and spatial analyses, new computational
approaches to infer cell state transitions, and our well-established platform for rapid genetic perturbations in
vivo, we will define the cell-intrinsic and cell-extrinsic events that lead to this p53-active transitioning cell state.
Furthermore, we will investigate the mechanisms by which activated p53 suppresses neoplastic transformation
in the transitioning cells, as well as the events that influence cancer initiation immediately following p53 loss.
This project will provide novel insight into the mechanisms that drive PDAC initiation and provide a direct and
detailed characterization of p53 in action in endogenous contexts. Given the high prevalence of TP53
mutations in human cancers, we expect the insights into tumorigenesis to be applicable to many cancer types.

Public health relevance
PROJECT NARRATIVE Genetic inactivation of the tumor suppressor p53 drives progression to malignancy during the initiation of pancreatic cancer. This proposal aims to investigate the mechanisms of p53 engagement and action during sporadic pancreatic cancer initiation, as well as the immediate consequences of p53 loss, using novel tools that allow us to examine the critical transition from benign to malignant disease. This work will provide insights into early events in the formation of pancreatic cancer and the many other p53-mutant cancers, and these insights may lead to new strategies for cancer prevention and treatment.